Mechanism of Yeast Transcriptional Regulators

The rewiring of transcriptional circuits is a major source of evolutionary novelty. This proposal seeks to determine the detailed molecular mechanisms that underlie transcriptional rewiring using unicellular yeasts as a model system. The strategy is based on direct experimentation in 15 yeast species?including Saccharomyces cerevisiae and Kluyveromyces lactis?and utilizes genome-wide transcriptional profiling, chromatic immunoprecipitation, phylogenetic comparisons, and ancestral protein reconstructions. Circuit comparisons among these yeasts uncover specific examples of transcriptional rewiring and deeper analyses reveal the molecular mechanisms by which the wiring changes occurred. Although some rewiring is probably neutral, much of it appears adaptive: indeed a major mechanism for evolutionary novelty involves rewiring transcriptional circuitry to allow new expression patterns of existing gene products. Thus, to truly understand the structures of transcription circuits in modern species, we need to know the mechanisms by which they rapidly evolve and how these mechanisms lead to and, thereby can account for, modern structures.

Public health relevance
PUBLIC HEALTH RELEVANCE: A cell carefully regulates the transcription of each one of its many genes. In humans, abnormalities in this complex process (whether inherited or acquired) can lead to many diseases, including a variety of cancers. Plasticity in transcriptional circuitry s well documented in the progression of normal cells to cancer cells, and a deeper understanding of it will provide insights into recognizing and perhaps treating cases where it leads to aberrant physiologies.